Understanding the Impact of Lower Dose Medroxyprogesterone Acetate on Female Genital Tract Microbiome and Immunology

Project Summary
The progestin-only contraceptive Depo-Provera 150mg delivered intramuscularly (150-IM), the most widely
used injectable contraceptive worldwide, has been associated with increased HIV acquisition in many
observational studies. The absence of causal evidence from randomized clinical trials has resulted in
uncertainty about whether the observed association is due to methodological limitations or a real biological
effect. Due to this uncertainty, and the risks associated with unplanned pregnancies, the World Health
Organization advises that women at high risk of HIV can continue to use progestin injectables with counseling.
Data on the effects of other long-acting contraceptives on HIV acquisition, such as implants and intrauterine
devices (IUDs) are even more scarce; and there are no data on Sayana® Press (DMPA-SQ 104mg,
hereafter 104-SQ) and other lower dose DMPA formulations in development. This study will leverage
three ongoing randomized trials to conduct timely, innovative, and cost efficient research to evaluate the
impact of multiple contraceptives – including 150-IM, the levonorgestrel (LNG) implant, the copper IUD, 104-
SQ, and novel low dose DMPA formulations - on the female genital tract (FGT) microbial and immune
environment. The aims of this research are to: 1) analyze the vaginal microbiome of women by 16S rRNA gene
survey and metagenomic sequencing for high-resolution analysis of bacteria, viruses, fungi, and parasites
before and after initiation of 150-IM, 104-SQ, LNG implant or Cu-IUD; 2) evaluate levels of vaginal cytokines
and antimicrobial proteins before and after initiation of 150-IM, 104-SQ, LNG implant or Cu-IUD; 3) evaluate
changes in the frequency and activation of CCR5+, CCR6+CCR10- (Th17-like) and α4β7 CD4+ T cells in the
cervix among women using 150-IM, 104-SQ, LNG implant or Cu-IUD; 4) evaluate changes in the vaginal
microbiome, cytokines and antimicrobial proteins with use of lower MPA doses (45, 75 and 105mg) compared
to 150-IM, and the effect of systemic and genital endogenous and exogenous hormone levels on these
outcomes; and 5) conduct a discovery metaproteomics analysis to evaluate alterations in vaginal human and
microbial proteins following initiation of 150-IM, 104-SQ, LNG implant or Cu-IUD. This research will clarify the
complex associations between contraceptive exposure, endogenous and exogenous hormones and the FGT
microbiome, markers of immunity and inflammation, recruitment of HIV target cells and activation of those cells
and markers of epithelial barrier repair. These data will inform contraceptive use and policy as well as provide
targets and safety endpoints for the development of future contraceptives. Moreover, these data will provide
the first evidence of FGT microbiome and immune changes that occur following initiation of other MPA
based contraceptives, including 104-SQ and novel low dose MPA formulations which will be critically
needed if the ECHO trial identifies increased acquisition of HIV among 150-IM users.

Public health relevance
Project Narrative A more complete mechanistic understanding of how different contraceptives modify the female genital tract (FGT) microbiome and immune response in ways that may alter HIV susceptibility is key to clarifying the conflicting results of epidemiologic studies of the impact of contraceptives on HIV acquisition, and to providing guidance for expansion and delivery of other long-acting contraceptives and progestin injectables, for which there are limited to no data, respectively, on risk of HIV acquisition. This study will leverage three randomized studies to conduct timely, innovative, and cost-efficient research to evaluate the impact of multiple contraceptives – including Depo Provera, the levonorgestrel implant, the copper intrauterine device, Sayana® Press (DMPA-SQ 104mg) and other novel low dose DMPA (45mg, 75mg, 105mg) formulations - on the FGT tract microbial and immune environment. These data will inform contraceptive use and policy, provide targets and safety endpoints for the development of future contraceptives, and provide the first evidence of FGT microbiome and immune changes that occur following initiation of DMPA-SQ 104mg and novel low dose MPA formulations.